A Randomized, Double-Blind, Placebo-Controlled, Parallel-Group, Phase 2 Study to Evaluate the Safety and Efficacy of CT1812 in Subjects with Dementia with Lewy Bodies

ABSTRACT: Cognition Therapeutics, Inc. (CogRx) is developing CT1812 for neurodegenerative conditions,
including Dementia with Lewy Bodies (DLB). This first-in-class small molecule drug candidate selectively
displaces Aβ oligomers bound to neuronal receptors at synapses and protects synapses from toxic oligomer
effects, clearing them from the brain into the cerebrospinal fluid (CSF). CT1812 also displaces α-synuclein
oligomer binding to neurons in vitro. CT1812 is currently in a Phase 2 trial in patients with mild to moderate
Alzheimer's disease (AD), where it has been found to be safe and generally well-tolerated. When administered
once daily for 28 days to AD patients, CT1812 significantly reduced concentrations of synaptic degeneration
markers in CSF. Similar to Aβ oligomers, α-synuclein oligomers bind to neurons and cause synaptic dysfunction
and loss, spreading throughout the brain as disease progression is observed in DLB. Eighty percent of patients
with DLB reflect both Aβ and α-synuclein pathology at autopsy. Patients with DLB likely have both types of
oligomers and should benefit from treatment with CT1812.
This clinical trial project proposes to conduct a Phase 2 randomized, double-blind, placebo-controlled, six-month
study to evaluate the safety, tolerability, and exploratory efficacy of CT1812 at 100 mg and 300 mg daily doses
in mild to moderate DLB patients (N=40/group). Trial endpoints will include safety as well as exploratory efficacy
measures (Montreal Cognitive Assessment [MoCA], Cognitive Drug Research Battery [CDR], Clinician
Assessment of Fluctuation [CAF], Epworth Sleepiness Scale [ESS], Movement Disorder Society – Unified
Parkinson's Disease Rating Scale – Part III [MDS-UPDRS3], The Alzheimer's Disease Cooperative Study –
Clinical Global Impression of Change [ADCS-CGIC], ADCS-Activities of Daily Living [ADL], and Neuropsychiatric
Inventory [NPI]) at baseline, 3 months, and 6 months. Additional measurements of plasma and CSF
concentrations of drug, target engagement biomarkers (including Aβ and α-synuclein oligomers), disease
progression protein markers (Aβ and α-synuclein monomer, total and phosphorylated tau protein) and synaptic
damage/neurodegeneration biomarkers (neurogranin, synaptotagmin, synaptosomal-associated protein 25
[SNAP-25], and neurofilament light [NFL]) at baseline and at 6 months will allow correlation of drug
concentrations with measures of synaptic damage and cognitive performance. Conducting a study with this
patient population will leverage the ongoing CT1812 development efforts for AD and will provide a near-term
opportunity to investigate a clinical candidate therapeutic in DLB, an indication for which no disease-modifying
treatments exist. Completion of this study will provide an initial assessment of CT1812 efficacy in DLB patients
that will inform design of subsequent pivotal trials necessary for further clinical development of CT1812.

Public health relevance
Project Narrative Cognition Therapeutics, Inc. proposes a Phase 2 clinical trial of CT1812, a novel disease-modifying compound, in patients with mild to moderate dementia with Lewy bodies (DLB). DLB is one of the most common cause of neurodegenerative dementia after Alzheimer's disease, and successful demonstration of CT1812 clinical efficacy could benefit millions of DLB patients for whom no other treatments are available, improving quality of life and reducing healthcare costs. When complete, this trial will provide clear evidence of the potential of CT1812 to improve cognitive performance in DLB patients, and provide meaningful data relating to the biology of DLB through biomarker assessments.